Using Daily Diaries to Trace Spillover Effects of Maternal Trauma on Children’s Stress Regulation

PROJECT SUMMARY/ABSTRACT
Maternal posttraumatic stress symptoms (PTSS) are a key factor explaining why maternal trauma has long-
lasting adverse effects on child development, even in circumstances where children do not directly experience
trauma. Mothers of color face elevated rates of trauma exposure and PTSS due to racism. Yet, there is virtually
no research examining the dual effects of racism and maternal PTSS on child development in families of color.
Better characterizing pathways by which maternal PTSS and racism experiences contribute to adverse child
outcomes is critical to disrupt the intergenerational transmission of trauma and advance health equity in
communities of color. Importantly, research on the spillover effects of maternal trauma on parenting and child
outcomes has focused solely on cumulative effects over months/years despite evidence that maternal PTSS and
parenting change daily. Daily inconsistency produced by these fluctuations may be an important mechanism
underlying intergenerational effects of maternal trauma, yet this is understudied. Moreover, increasing attention
is being paid to biological effects of maternal trauma given evidence that changes in physiological systems such
as the hypothalamic-pituitary-adrenal gland (HPA) axis precede the emergence of behavior problems.
The proposed study examines associations between maternal experiences of racism, daily maternal PTSS and
parenting, and child HPA axis functioning. Participants are mothers of color with PTSS with a child aged 3-5
years (N = 100). Mothers will complete an initial survey assessing her baseline PTSS, parenting, and
experiences of racism, followed by a 14-day daily diary collection regarding daily PTSS symptoms and parenting.
At the end of the daily diary period, three saliva samples per day for three days will be collected from the child
to assess diurnal cortisol. In Aim 1, we will explore same-and next-day associations between PTSS severity and
parenting, as well as how daily variability in PTSS relates to parenting inconsistency. Aim 2 will examine how
daily maternal factors (PTSS, parenting) relate to child HPA axis functioning (diurnal cortisol slopes). Aim 3
explores the moderating effects of maternal racism experiences on pathways between daily PTSS and child
HPA axis functioning, as well as daily PTSS and parenting.
The research team (MPIs Stein and Galano; Co-Is Mercado, Miller, and Laws; Consultant: Levendosky) is
uniquely positioned to address study aims given expertise in the intergenerational transmission of trauma in early
development, HPA axis functioning, and intensive longitudinal designs with traumatized women of color.
The proposed research is innovative in its focus on daily processes of the intergenerational transmission of
trauma and on contextual moderators relevant to families of color. Given the pervasive effects of maternal trauma
on child outcomes this work has important public health significance. Findings will inform an R01 submission to
test full mediational pathways between daily PTSS and child HPA axis functioning.

Public health relevance
PROJECT NARRATIVE Maternal posttraumatic stress symptoms (PTSS) exert strong effects on early childhood (ages 3-5 years) development outcomes, with mothers of color experiencing disproportionately high rates of traumatic stress. Increasing attention is being paid to biological mechanisms connecting maternal PTSS and childhood outcomes considering evidence that changes in hypothalamic-pituitary-adrenal (HPA) axis functioning precedes the emergence of behavior problems. The proposed study examines daily associations between maternal PTSS, parenting, and children’s HPA axis functioning in families of color, while also investigating the moderating effects of maternal experiences of racism on paths from maternal PTSS to related outcomes.